Mitochondrial DNA and Sex Differences in Scleroderma-Associated ILD

ABSTRACT
Scleroderma (SSc) is a multisystem disease characterized by cutaneous and visceral fibrosis that most
commonly affects the lung. Nearly 70% of patients with SSc experience clinically significant interstitial lung
disease (SSc-ILD) that in 50% will lead to death within ten years of diagnosis. For unknown reasons, women are
more commonly affected, yet men have worse clinical outcomes. Defining the molecular mechanisms of SSc-
ILD sex differences may eradicate these disparities and improve patient care. SSc-ILD is believed to result from
immune-driven accumulation of transforming growth factor beta (TGFβ)-1 responsive, extracellular matrix
(ECM)-producing inflammatory fibroblasts. Innate immune pattern recognition receptors and their endogenous
ligands are implicated in this process. The endosomal innate immune receptor Toll-Like Receptor 9 (TLR9),
which recognizes and responds to danger associated molecular patterns such as mitochondrial DNA (mtDNA),
has a recently discovered role in SSc-ILD. We found that SSc-ILD fibroblasts exhibit spontaneous mtDNA
release and TLR9 activation. Extracellular mtDNA concentrations are increased in SSc-ILD bronchoalveolar
lavage and plasma where they predict disease progression. Relative to their male counterparts, women with
SSc-ILD show plasma mtDNA that is more bioactive and lung explants that are enriched for TLR9-responsive
inflammatory genes. In chronic SSc-ILD mouse models, females show greater mtDNA bioactivity, TLR9
activation, and a stronger therapeutic response to pharmacologic TLR9 inhibition. The heightened inflammation-
promoting consequences of mtDNA-TLR9 interaction in women could explain sex differences in clinical
phenotypes experienced by SSc-ILD patients. Our world class team of experts will test the hypothesis that
differential interactions between extracellular mtDNA and TLR9 drive SSc-ILD sexual dimorphism. Aim 1 will
advance the study of extracellular mtDNA, TLR9, and SSc-ILD sex differences by a) characterizing extracellular
mtDNA and TLR9 activation in SSc-ILD BAL samples from women and men; and b) using single nuclear
sequencing and protein-based assays to compare TLR9 expression/activation in archived, explanted lung tissue
specimens from women and men with SSc-ILD. Aim 2 will define mechanisms of sexual dimorphism in the
extracellular mtDNA-TLR9 relationship in experimental mouse models of chronic lung fibrosis using a)
pharmacologic and b) genomic methods in a tamoxifen-inducible model of fibroblast-specific Tlr9 deletion and
two chronic models of SSc lung fibrosis. Aim 3 will probe sex differences in fibrogenic extracellular mtDNA-TLR9
interactions in human lung fibrosis using genetic and pharmacologic strategies in primary lung fibroblasts and a
next generation model of lung fibrosis based on TGFβ1-stimulated human lung cores. If successful, these
studies will frame extracellular mtDNA-TLR9 interactions as drivers of SSc-ILD sexual dimorphism and identify
mechanisms that can be leveraged for the betterment of human health.

Public health relevance
PROJECT NARRATIVE Scleroderma-associated interstitial lung disease is an incurable autoimmune condition characterized by varying degrees of inflammation and fibrosis. Women are more commonly affected, and men have worse clinical outcomes. This project will use primary human samples, cell specific knockout mice, and next generation modeling systems to determine whether interactions between endogenous innate immune ligands such as mitochondrial DNA, and innate immune pattern receptors such as Toll Like Receptor 9, contribute to these sex differences with the goal of discovering treatments that can improve the health of all patients.